Immune Oncology

IMMUNE ONCOLOGY PROGRAM
PROJECT SUMMARY/ABSTRACT
The objectives of the Immune Oncology (IO) Program are to improve cancer diagnosis, care and cure rates
through better understanding of molecular and cellular interplay between cancer cells and the immune system
and optimizing the efficacy of cellular and molecular immunotherapies and stem cell transplantation (SCT).
Program members investigate the roles of immune and cellular processes in health and disease, discover the
contribution of host-derived genetic and molecular contributors to immune evasion, overcome mechanisms of
resistance and tolerance to immune therapies by cancer cells, improve current and new roles of innate and
adaptive immunity in immune responses to both liquid and solid cancers, and create a portfolio of translational
application focusing toward developing new cell-based and immune-modulating treatments for both solid tumors
and hematological malignancies. The program is organized around 3 scientific aims: 1) Elucidate the genetic
and molecular mechanisms that control antitumor immunity and recognition of cancer cells by immune cells 2)
Discover novel strategies to overcome acquired and/or adaptive immune resistance to adoptive cell therapy,
tumor vaccines, immune checkpoint blockade and other immune-based approaches 3) Develop clinical trials
leveraging novel molecular, cellular and immune cancer therapeutics, such as cell-based therapies,
hematopoietic SCT and small molecule immune modulators. These aims reflect major working groups and
initiatives that coalesces program members with other cancer center investigators through inter-programmatic
collaborations that result in preclinical and clinical research efforts, grants, and trial protocols. Extensive use of
an array of shared resources, in particular, Genomics, Hematopoietic, Cytometry, Biostatistics, Tissue, and
Translational Research facilitate all aspects of member discoveries. Under the leadership of Timothy Chan (Co-
Leader), David Wald (Co-Leader) and Alex Huang (Co-Leader) the IO Program has 48 full members representing
11 different departments across all 3 consortium institutions. Members are funded with a total of $14.7M in grant
funding (annual direct costs), of which $7.3M is peer-reviewed and $4.4M is NCI-funded. During the last funding
period, IO program members published 1,194 cancer-focused publications. Cancer and program related
publications included 34% inter-programmatic and 25% intra-programmatic publications. This highly effective
program has made major practice-changing contributions benefiting cancer patients. Examples include: the
discovery of POLE/D1 functional mutations that impact sensitivity to immune checkpoint blockade, the clinical
translation of multiple novel cell therapy products including a BAFF CAR-T product and ultra-fast (<1 day
manufacturing) CAR-T products for myeloma and lymphoma, and the clinical translation of multiple approaches
to target TGF-beta in cancer including a multi-center international clinical trial for pediatric osteosarcoma.